Project 3: Nicotine Product Claims on Appeal, Perceptions, and Use Behavior

SUMMARY – PROJECT 3
Oral nicotine pouches (ONPs) emerged in the U.S. in 2016, ONP brands rapidly proliferated, and sales are
skyrocketing. ONPs are representative of a shift by the tobacco industry to marketing non-tobacco nicotine
products as alternatives to cigarettes, smokeless tobacco (ST), and even e-cigarettes (ECs). Nicotine is the
driver of use and dependence, and the industry continuously manipulates nicotine dimensions to maximize
appeal to consumers. Packaging is a primary marketing vehicle to increase product appeal, and ONP packaging
prominently emphasizes nicotine concentration (e.g., 3 mg, 6 mg) and source claims (e.g., “tobacco free”) as
a marketing tool. Understanding how these packaging features communicating nicotine dimensions affect the
appeal of ONPs in young adult non-users versus adult tobacco users is critical to inform regulations for ONPs
and other nicotine products using similar marketing. Project 3 of the Ohio State University Tobacco Center of
Regulatory Science (OSU-TCORS) will examine how nicotine concentration and source claims on ONP
packaging affect the appeal of ONPs and how these features affect preferences for ONPs relative to ECs,
cigarettes, ST, and other products in young non-tobacco users versus adult tobacco users. The Specific Aims
are to: 1) Examine the effects of nicotine concentration and source claims on visual and cognitive engagement
with ONP packaging using laboratory-based psychophysiological assessment. 2) Examine the effects of nicotine
concentration and source claims on ONP perceptions, behavioral intentions, and ONP trial. 3) Investigate the
effects of nicotine concentration and source claims on ONP preferences relative to ECs, cigarettes, ST, and
other tobacco products. Project 3 includes 2 complementary studies to accomplish these aims. Study 1 (Aims
1 and 2) is a 2 (young adult susceptible non-user, adult tobacco user) x 3 (labelled nicotine concentration: none,
low, high) x 3 (source claim: none, “tobacco free,” “synthetic”) human laboratory experiment to examine how
nicotine concentration and source claims affect engagement with ONP packaging using psychophysiological
measures, ONP appeal, risk perceptions and use intentions, and a behavioral lapse task assessing ONP trial.
Study 2 (Aim 3) is a discrete choice experiment with a national sample of young adult susceptible non-users and
adult tobacco users to assess the effects of nicotine concentration and source claims on ONP preferences
relative to ECs, cigarettes, ST, and other products. Project 3 addresses the Marketing Influences and Behavior
FDA tobacco regulatory science domains. Project 3 is significant and innovative because it will be one of the
first studies to generate evidence to inform potential regulation of packaging features communicating nicotine
concentration and nicotine source claims based on their differential effects in young adult non-users versus adult
tobacco users. Together with Projects 1, 2, and 4, the OSU-TCORS will provide evidence to guide an overall
regulatory strategy targeting nicotine dimensions for ONPs, ECs, and other novel products.

Public health relevance
The tobacco industry has historically manipulated nicotine in its products to increase their appeal and potential for addiction for the widest possible audience, including young people and non-users. They are now doing this with newer products, like e-cigarettes and oral nicotine pouches. Our center will study how these manipulations affect young people and adults, with the goal of helping the FDA develop regulations that will make these products less appealing to young people, including non-users, but not older adult smokers and smokeless tobacco users who may benefit from their use.